USE OF STEPWATCH ACTIVITY MONITOR IN CHILDREN

Two groups of 6 able bodied children from 5-6 years and 8-9 years will be recruited and undergo evaluation using the StepWatch activity monitor. This custom computerized accelerometer will record total activity and patterns of activity for our subjects over two week intervals. Each child will undergo two testing periods during different seasons. The data will provide preliminary information regarding a child's primary daytime function, play.